HIV INF PATIENTS RECEIVING PROTEASE INHIBITORS WHO DEVELOPED DIABETES

The study aims to evaluate the relationship between protease inhibitors and Diabetes Mellitus and determine pathogenesis of this drug effect. The study involves a descriptive analysis of 10-20 cases characterizing demographic and individual risk factors. A modified IVGTT will be performed with in 1 month of enrollment to evaluate the severity of insulin resistance as a possible etiology for protease inhibitors related hyperglycemia. The modified GTT requires the collection of 15 serial blood samples over a 3 hour period following administration of IV glucose and insulin. A 2nd IVGTT may be performed several months after stabilization of Diabetes Mellitus on therapy.